Efficient and Long-lived Brain Delivery of Neutralizing Antibodies Against Eastern Equine Encephalitis Virus for Post-exposure Therapy

Eastern equine encephalitis virus (EEEV) is a lethal alphavirus transmitted by mosquitoes. Aerosol exposure to
the virus results in rapid viral entry into the brain via the olfactory neuroepithelium. While potently neutralizing
antibodies have been identified that provide some post-exposure protection when the virus is administered
subcutaneously (especially at early time points), they are much less effective when administered after aerosol
exposure. The lack of therapeutic protection in the latter case is likely due to the inability of antibodies to
efficiently penetrate the blood-brain barrier (BBB) and neutralize and/or clear virus already in the brain. Given
that clinical diagnosis is typically not made until patients manifest symptoms of encephalitis, the availability of
therapeutics capable of efficiently penetrating the BBB and inhibiting virus that has already entered the CNS
represents a major unmet medical need for EEEV, and arguably for all other encephalitic viruses. The overall
objective of this proof-of-concept study is to address this need by developing BBB-penetrating bispecific
antibodies (bAbs) for rapid, concentrated, and sustained delivery of anti-EEEV neutralizing antibodies to the
brain after IV administration. Members of our team (Tessier and Greineder) recently reported bAbs that target
CD98hc – the heavy chain of the large neutral amino acid transporter (LAT1) – and mediate the delivery of IgGs
into the brain parenchyma after IV administration. Notably, we observe superior brain retention and less
parenchymal cellular internalization of IgGs shuttled via CD98hc compared to those shuttled via transferrin
receptor-1 (TfR-1). Moreover, we (Diamond) have identified a panel of potently neutralizing mAbs against EEEV
and confirmed their protective ability in lethal challenges in mice at early but not late time points. Here, we
propose to test our primary hypotheses that anti-EEEV/CD98hc bAbs will be both i) effective at protecting
against direct intracranial inoculation of EEEV (Madariaga strain) and ii) more protective than equivalent TfR-1
bAbs. Therefore, in Aim 1, we will evaluate the impact of anti-EEEV antibody, level of Fc-mediated effector
functions, and dose on the kinetics of brain uptake, maximum brain levels, and potential dose-limiting toxicities
of anti-EEEV/CD98hc bAbs relative to equivalent TfR-1 bAbs. Next, in Aim 2, we will evaluate the therapeutic
effectiveness of anti-EEEV/CD98hc bAbs relative to equivalent TfR-1 bAbs after intracranial administration of
EEEV-Madariaga. A key outcome of this study will be the evaluation of the feasibility of using bAbs with advanced
properties to protect against EEEV-mediated lethality after the virus has entered the brain. We expect to identify
key factors that impact antibody-mediated protection after intracranial administration, which could inform the
design of therapeutics against other viruses that involve brain-mediated lethality.

Public health relevance
This proposal aims to improve the brain delivery of neutralizing antibodies against Eastern equine encephalitis virus (EEEV), a lethal virus transmitted by mosquitoes. Because the virus efficiently enters the brain and causes lethality, this research seeks to develop and test multifunctional antibodies that penetrate the blood-brain barrier and efficiently neutralize the virus after it has entered the brain. Successful completion of this research would accelerate the development of effective post-exposure therapeutics for treating EEEV infections.